Real-time Analysis for the Phylogenetic Investigation of Drug-resistant HIV clusters (RAPID-HIV)

Project Abstract
The overall aim of this project is to enable real-time surveillance of HIV-1 drug resistance and transmission
clusters using an integrated computational pipeline and novel amplicon approach that we have developed
for nanopore sequencing. This project is important because globally the rise of resistance to ART is
threating the significant progress made in suppressing the virus. In Africa, this threat is particularly acute
where several countries have reported levels of pre-treatment HIV resistance exceeding 10% to the
standard first-line therapy. The advent of portable sequencing technology means viral genomic sequencing
is now positioned to exert a greater impact on the public health response to the upsurge in resistance. In
this proposal we will use the MinION sequencing device and assess the performance characteristics
(accuracy, specificity, sensitivity) of a novel amplicon-based approach in order to accurately characterize
HIV-1 diversity using full-length pol amplicons. Owing to the biased nucleotide composition of the HIV-1
genome and the complexity of the raw nanopore data we will identify how we can improve raw read
accuracy and simplify the analysis of nanopore sequencing data by non-bioinformatics experts. Based on
the elevated HIV-1 risks within Ugandan fishing communities we hypothesize that viral clusters from
fisherfolk frequently harbor drug-resistance mutations and act as reservoirs of resistance. Thus, we need to
understand the transmission dynamics and evolution of transmitted drug resistance within HIV-1 infected
fishing communities around Lake Victoria. This proposal will integrate sequencing, basecalling, and
analysis in near real-time using an integrated workflow to enable HIV-1 drug resistance surveillance and
the detection of transmission clusters. To achieve these objectives, we will use a panel of HIV-1 samples
comprising locally circulating strains in order to evaluate the performance characteristics of our amplicon
sequencing approach to accurately characterize HIV-1 diversity using full-length pol amplicons. We will
develop custom trained basecalling models specific to HIV-1 to accurately quantify drug resistance and
implement an integrated analysis pipeline for real-time genotyping and drug resistance reporting to simplify
the analysis of nanopore sequencing data by non-bioinformatics experts. Lastly, we will use our recently
developed amplicon sequencing approach coupled with our real-time analysis pipeline to understand the
transmission dynamics and evolution of transmitted drug resistance within HIV-1 infected individuals from
fishing communities around Lake Victoria. Together, these results will advance our understanding of the
transmission dynamics of HIV-1 among fishing communities and evaluate the burden of resistance among
this high-risk sub-population.

Public health relevance
Narrative Given the burgeoning levels of resistance to first line therapy there is an urgent need for better surveillance tools to prevent the further emergence and spread of resistant strains. Currently there are limited data on the transmission of HIV-1 drug resistant strains in the context of high-risk sub-populations in Uganda such as the fisherfolk communities surrounding Lake Victoria. This study will develop a framework to enable detection of HIV-1 transmission clusters and drug resistance mutations in near real-time using an integrated workflow that we have developed for nanopore MinION sequencing.